Midbrain Circuits for Perceptual Decision-Making

ABSTRACT
Perceptual decision-making is a fundamental cognitive ability that is vital to healthy, daily functioning and is
impaired in many diseases. Although many brain regions are known to be involved, there is no clear brain-wide
model of how perceptual decisions are formed and executed and the underlying circuit mechanisms are still
largely unknown. Here, a team of investigators propose a series of experiments that will use behavioral
measures, imaging, physiology, circuit dissection, and computational modeling to study how the midbrain
superior colliculus (SC) participates in visual decision-making. Specifically, this new team of investigators will
probe the contribution of two SC neuronal cell types, wide field vertical (WFV) cells in the visuosensory layers
and predorsal bundle (PDB) cells in the motor layers. These experiments will be done in mice and tree shrews,
to reveal the underlying circuits and computational principles across species and to lay the foundation for future
experiments designed to dissect decision-making circuits in primates. In Aim 1, the investigators will establish
and perform psychophysical experiments to assess perceptual decision-making in both species. The behavioral
data will be fitted with computational models to arbitrate between different theories of decision-making. In Aim 2,
two photon calcium imaging and/or physiological recording will be performed in mice and tree shrews to
determine the activity of WFV and PDB neurons during the psychophysical measures established in Aim 1. In
addition, WFV and PDB neurons will be silenced optogenetically during the behavioral tasks to reveal their
specific roles in decision-making. In Aim 3, the investigators will use intersectional monosynaptic viral tracing
techniques, multiplexed peroxidase labeling for confocal and ultrastructural analysis of synaptic connections and
and optogenetics-assisted brain slice recording to investigate the intrinsic and extrinsic circuits that link WFV
and PDB cells. Together, these experiments will generate novel knowledge of the synapse to circuit mechanisms
underlying perceptual decision-making, and provide technical and theoretical foundations for future mechanistic
studies of cognitive function in higher mammalian species directly relevant to humans.

Public health relevance
PROJECT NARRATIVE The goal of our research is to reveal the neural basis of perceptual decision-making. Decision-making is vital to healthy, daily functioning and is impaired in many diseases, ranging from mild cognitive impairment to Alzheimer’s disease, Parkinson’s disease, schizophrenia, and even neurodevelopmental disorders including autism and attention deficit hyperactivity disorder (ADHD). Our studies will contribute to the understanding and treatment of these diseases and increase the knowledge of decision-making in normal development and aging.